Building and implementing a TBI prognostic model featuring real-time analysis of brain CT images

Scope of Work
Duke will complete all work for the machine learning model building and implementation of the model into the
Duke clinical workflow. For Aim 1 of the project, this work will include data extraction and cleaning, neural network
architecture design, and model optimization and validation. For Aim 2, this work will include establishment of
technical infrastructure for real-time image and access and processing, construction of a front-end dashboard in
close collaboration with frontline clinicians, and deployment and prospective validation of the model. The latter
step will also consist of education and training of hospital users. For Aim 3 of the project, Duke will guide staff at
Jefferson through the model implementation and validation process, with the active integration and training
performed by staff at Jefferson. In Aim 3 Duke will also run the experiments on multi-site model generalization,
using retrospective data at both Duke and Jefferson. Data will be shared between Duke and Jefferson via secure
ethernet transfer between Jefferson’s secure data warehouse and Duke’s Protected Analytics and Computing
Environment. The end goal of the work will be to provide a sophisticated, high-accuracy, and seamlessly
integrated tool for predicting the risk of actionable TBI complications over the course of a TBI patient’s hospital
encounter. This method, which will augment decision-making for treating a complex neurological condition, will
significantly improve overall TBI outcomes, reduce readmission rates, and minimize the extraordinary costs
incurred by inefficient provision of healthcare resources.

Public health relevance
Project Narrative Traumatic brain injury (TBI) affects the lives of an estimated 5 million patients each year, but it is notoriously difficult to treat due to great complexities in diagnosis and prognosis. We will leverage large-scale EHR data from 17 hospitals across two healthcare systems to train, deploy, and prospectively validate a cutting edge deep learning model that uses real-time discrete patient data and raw CT image volumes to predict patient risk for a set of key actionable TBI complications. By referring to the model’s interpretable predictions and how they change across time, frontline providers in emergency rooms, in-patient units, and neurosurgery units will make better decisions about treatment and withdrawal of care, meaning the threat of this ubiquitous and devastating condition will be minimized.